Fluorescent Biosensors to Illuminate Chloride Homeostasis and Signaling

PROJECT SUMMARY
Chloride is the most abundant inorganic anion in the human body. It is required for essential physiological
functions ranging from electrolyte balance, acidosis, innate immunity, circadian rhythms, and even taste
sensation. However, disruptions in chloride homeostasis, arising from diet or genetics, are linked to diseases
including cystic fibrosis, hearing loss, kidney stones, myotonia, and osteopetrosis, as well as cancers, cardiac
dysfunction, and neurological disorders. To dissect the contributions of chloride in healthy and disease states, a
fundamental understanding of its distribution, regulation, and biomolecular targets at the cellular level is needed.
As a step towards this long-term goal, the proposed research program will engineer and apply new fluorescent
protein-based imaging technologies to monitor and measure chloride in living systems across time and space
dimensions. Over three independent project directions, innovative strategies will be used to address practical
gaps in biosensor design, while at the same time rigorous and reproducible biological applications will be
established in user-friendly cell lines to democratize chloride imaging. Ultimately, the resulting technologies will
illuminate chloride in fundamental biological processes that are dysregulated in disease, leading the way to
therapeutically target this vital anion for improving human health.

Public health relevance
PROJECT NARRATIVE Chloride ions are required for essential functions in the human body, spanning electrolyte balance, acidosis, innate immunity, circadian rhythms, and even taste sensation. At the same time, dysregulated chloride levels have been linked to diseases such as cystic fibrosis, hearing loss, hypertension, kidney stones, osteopetrosis, and pain. We are engineering new technologies for imaging chloride in living systems to fundamentally understand how cells store and regulate chloride in homeostasis and signaling, paving the way ultimately to therapeutically control this anion for the betterment of human health.